Practical Application of HACCP for Regulators, Operators, and the Community

ABSTRACT The Multnomah County Environmental Health (MCEH) Food Safety Program regulates the food retail industry in Multnomah County, Oregon. Multnomah is the most populous and diverse county in Oregon, accounting for nearly 20% of the state's population. MCEH is proposing the multi-faceted Practical Application of HACCP for Regulators, Operators, and the Community project to build regulatory and industry capacity to use and regulate food systems based on the principles on Hazard Analysis and Critical Control Points (HACCP) within Multnomah County. The current food retail context in Multnomah County is comprised of a diverse terrain, including restaurants specializing in local foods and foods that require special processing, food carts selling high-risk edibles, and a micro-enterprise movement that, at present, is completely unlicensed and unstandardized. The overall goal of this project is to assist local food establishments and street vendors in improving food safety through the application of HACCP- based principles to their small businesses. The Specific Aims of this project are to: 1. Increase the competency and capacity of local MCEH staff to approve, monitor and inspect food processes based on HACCP principles. 2. Increase food service industry awareness of HACCP principles. 3. Improve the competency and ability of food service industry, including food cart vendors, to use the principles of HACCP and develop HACCP plans for food processes that require them under the newly adopted food code. 4. Enhance systems to support the success of unlicensed and nontraditional food service operators in their conformance with the standards. 5. Evaluate the effect of Food Code adoption on violations, scores, inspection time and support needs for food service industry operators to achieve compliance. Applying HACCP principles to restaurants and mobile units, special processing performed by facilities, and food-related microenterprises, some of which are home-based, will provide a standardized way to identify risk factors and obtain immediate- and long-term corrective action for those that are recurring. This will ultimately result in a reduction of food-borne illnesses.

Public health relevance
PROJECT NARRATIVE The goal of this proposal, entitled "Practical Application of HACCP for Regulators, Operators, and the Community," is to assist local food establishments and street vendors in Multnomah County, Oregon to improve food safety through the application of HACCP-based principles to their small businesses. Applying HACCP principles to restaurants and mobile units, special processing performed by facilities, and food-related microenterprises, some of which are home- based, will provide a standardized way to identify risk factors, and obtain immediate- and long- term corrective action for those that are recurring. This will ultimately result in a reduction of food-borne illnesses. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The Multnomah County Environmental Health (MCEH) Food Safety Program regulates the food retail industry in Multnomah County, Oregon. MCEH is proposing the multi-faceted "Practical Application of HACCP for Regulators, Operators, and the Community" project to build regulatory and industry capacity to use and regulate food systems based on the principles on Hazard Analysis and Critical Control Points (HACCP). Restaurant food makes a significant contribution to food-borne illness because of complex inputs and outputs, multiple processes, and numerous handlers. The current food retail context in Multnomah County is comprised of a diverse terrain, including restaurants specializing in local foods and foods that require special processing, food carts selling high-risk edibles, and a micro-enterprise movement that, at present, is completely unlicensed and unstandardized. HACCP plans improve food safety in restaurants and can help operators identify the critical control points that create risk in special processes. We hypothesize that similar to the improved outcomes of restaurants with HACCP plans, providing tailored HACCP-based information to street vendors, whether they currently have food carts or are producing food in home kitchens, could improve food safety outcomes in those ventures. The adoption of the 2009 Food Code in Oregon, and the regional interest in artisan and local food products, provides a strategic opportunity to promote HACCP to an engaged and receptive food service and retail audience. We will strategically focus on conformance with Food Regulatory Program Standards 2, 3, and 8 and maintenance of our success with 4, 5, 6, 7 and 9. The overall goal of this project is to assist local food establishments and street vendors to improve food safety through the application of HACCP-based principles to their small businesses. Applying HACCP principles to restaurants and mobile units, special processing performed by facilities, and food-related microenterprises, some of which are home-based, will provide a standardized way to identify risk factors, and obtain immediate- and long-term corrective action for those that are recurring. This will ultimately result in a reduction of food- borne illnesses. The Specific Aims of this project are to: 1. Increase the competency and capacity of local MCEH staff to approve, monitor and inspect food processes based on HACCP principles. 2. Increase food service industry awareness of HACCP principles. 3. Improve the competency and ability of food service industry, including food cart vendors, to use the principles of HACCP and develop HACCP plans for food processes that require them under the newly adopted food code. 4. Enhance systems to support the success of unlicensed and nontraditional food service operators in their conformance with the standards. 5. Evaluate the effect of Food Code adoption on violations, scores, inspection time and support needs for food service industry operators to achieve compliance.